Home-Based, Digital Intervention to Increase Physical Activity in Patients with the Fontan Circulation

SUMMARY/ABSTRACT
Patients who undergo cardiac surgeries to establish the Fontan circulation (FC) suffer from lifelong complications
and early mortality. Engaging in physical activity (PA) may help to counteract these negative consequences.
Youth with the FC engage in less physical activity (PA) than their peers and demonstrate decreased aerobic
performance and lower skeletal muscle mass portending worse clinical outcomes. We now know that patients
with the FC can safely engage in PA and improve their aerobic exercise performance in hospital-based exercise
programs. Unfortunately, these programs are highly selective, costly, and inconvenient, and thus not
generalizable or equitable. Digital health applications can mitigate these barriers by remotely promoting PA
beyond the point of care, especially with caregiver support. However, gaps in knowledge remain about whether
a home-based digital intervention can 1) increase PA and 2) improve aerobic performance and increase skeletal
muscle mass and muscle strength, in youth with the FC. Thirdly, from an equity standpoint, it is not known how
individual, family and neighborhood level factors influence the effectiveness of a home-based PA intervention.
Thus, there is a critical need to develop and test innovative digital interventions to improve PA and clinical
outcomes among all youth with the FC. The study team’s objective is to evaluate the efficacy of a digital
intervention to increase PA and clinically relevant measures of physical fitness in youth with the FC. To
accomplish this, the team proposes a randomized controlled trial with three specific aims. A wrist-worn physical
activity tracker will be given to all participants, but they will be randomized to “enhanced usual care” (tracker plus
standard encouragement to exercise) or a digital PA intervention for 6-months. The intervention arm will include:
(1) personalized aerobic-based physical activity, (2) personalized resistance exercise sessions, and (3) financial
and non-financial engagement strategies, targeting youth and caregivers. These intervention components will
be delivered using an advanced mobile health informatics platform. Clinical assessments will be made at
baseline, 6 months, and 12 months. Under aim 1, we will determine if the multi-component digital intervention
increases PA levels in youth with the FC. Under aim 2, we will determine if the intervention leads to
improvements in physical fitness outcomes (aerobic capacity, muscle mass, and strength). Finally, under aim
3, we will test whether medical, neurodevelopmental, sociodemographic and/or neighborhood factors, are
associated with the efficacy of the digital intervention, using qualitative and quantitative approaches. It is
anticipated that the digital intervention will significantly increase PA and improve physical fitness. Further,
multi-level factors will be identified that associate with the efficacy of the intervention, thus providing
the foundation for future implementation trials. These findings will lead to the integration of equitable
and sustainable digital PA interventions for youth with a FC in the pediatric cardiology clinical setting.

Public health relevance
NARRATIVE The proposed research is relevant to public health because the prevalence of physical inactivity in children with the FC is excessively high and consequently, they have reduced physical fitness and poor long-term outcomes. Pediatric cardiology teams should promote physical activity in children with the FC, but currently they lack the necessary tools to do so in the home setting. This project aims to develop and test the efficacy of a mobile health platform for pediatric cardiology teams to promote physical activity in children with the FC and is relevant to the NHLBI’s mission to develop and optimize novel therapeutic strategies to treat heart disease.